MOLECULAR DISSECTION OF SEIZURE MICROENVIRONMENT IN MALIGNANT GLIOMA

Glioblastoma cells trigger pharmacoresistant seizures that may promote tumor growth and diminish the quality
of remaining life. To define the relationship between growth of glial tumors and their neuronal
microenvironment, and to identify genomic biomarkers and mechanisms that may point to better prognosis and
treatment of drug resistant epilepsy in brain cancer, we are analyzing a new generation of genetically defined
CRISPR/in utero electroporation inborn glioblastoma (GBM) tumor models engineered in mice. The molecular
pathophysiology of glioblastoma cells and surrounding neurons and untransformed astrocytes will be
compared at serial stages of tumor development in three genetic mouse strains: wild type, seizure prone, and
seizure resistant. Preliminary data reveal that epileptiform EEG spiking is a very early and reliable preclinical
signature of GBM expansion preceding other neurological deficits in these mice, followed by rapidly
progressive seizures and death within weeks. Transcriptomic analysis of cortical astrocytes reveals the
expansion of a subgroup enriched in pro-synaptogenic genes that may drive hyperexcitability, a novel
mechanism of epileptogenesis. In Specific Aim 1 we will systematically define the earliest appearance of
cortical hyperexcitability in wild type mice with a prototypical GBM and correlate its progression with in vivo and
neuropathological imaging of invasive tumor cell location, in vitro electrophysiology, and molecular markers of
key epilepsy pathogenic cascades in peritumoral neurons, including impaired glutamate reuptake, altered
GABA gated-chloride gradients, and synaptic densities. In Specific Aim 2 we will correlate these findings with
detailed FACS-sorted transcriptomic profiles of both transformed and wild type astrocytes in the peritumoral
region to test the novel hypothesis that peritumoral hyperexcitability is driven in part by astrocytic subtypes that
disrupt synaptic E/I homeostasis. In Specific Aim 3, we will use this benchmark approach in WT brain to
compare growth, electrophysiological and molecular pathological profiles of the same tumor generated in a
hyperexcitable brain bearing a single gene deletion (Kcna1) that dramatically lowers the threshold for seizures
and shortens lifespan, and in a monogenic deletion strain (MapT/tau) that raises cortical seizure threshold and
prolongs life, in order to examine the contribution of host neuronal excitability to tumor expansion. Our
approach sets the stage to broadly explore the developmental biology of personalized tumor/host interactions
in mice engineered with novel human tumor mutations in specified glial cell lineages.

Public health relevance
These studies utilize a next-generation in utero electroporation mouse model of glioblastoma to study mechanisms of epileptogenesis and neural control over tumor growth within the developing mouse brain. We will identify the sequence of early malignant cellular excitability biomarkers leading to hyperexcitability in neuronal circuits and surrounding glia that precede the first clinical seizure and examine the contribution of malignant astrocytes to excess synaptogenesis in the peritumoral margins. Comparisons of these changes with those found in the tumor microenvironment at later stages and on permissive and suppressant genetic backgrounds allow the dissection of causative vs reactive changes and the effect of neural activity on tumor growth.